Community Engagement Core

COMMUNITY ENGAGEMENT CORE: PROJECT SUMMARY/ABSTRACT
The Community Engagement Core (CEC) supports the mission of the Southern California Environmental Health Sciences
Center (SCEHSC) through engagement of community partners in a collaborative multidirectional process to identify and
address the effects of the environment on human health in Southern California (CA). The CEC serves as a national leader
in and model for engagement with communities—especially those living under economic hardship and facing
disproportionate adverse health outcomes from social and environmental exposures. The CEC primary target. audiences
include communities, primarily reached through community-based organizations, together with policymakers and health
professionals to address: (a) transportation-related air pollution and impacts on health, which has evolved directly from
key SCEHSC research findings showing air pollution to be one of Southern CA’s. leading environmental health issues;
(b) concerns about health impacts from goods movement facilities, including marine ports, railyards and inland
warehouses; and (c) broader health and emerging air quality concerns arising from land-use decisions such as locating
industries adjacent to homes and schools. Over the past 24 years, the CEC has developed a successful model to listen to
the community and engage community-based organizations and decision-makers in addressing environmental
health effects of traffic and goods movement in Southern CA. During the current cycle, we built on this approach to
integrate novel methods to train residents and health professionals in participatory air monitoring, to collaborate with
multiple stakeholders to assess and reduce toxic air emissions at a neighborhood scale, and to expand our engagement
program to address growing concerns around industrial facilities across the region. We leverage traditional and
nontraditional communications techniques such as digital StoryMaps, social media, and infographics to update
stakeholders on current science and engage the power of communities to reduce EH burdens. In this next cycle we aim to:
1) Facilitate a multidirectional communication structure that fosters interaction, share SCEHSC research findings and
engagement models with local/regional/national audiences, and increase SCEHSC investigators’ understanding of
community concerns with guidance from our community advisors; 2) Build capacity of community organizations to
respond to environmental health burdens and to address those burdens through community science; 3) Disseminate
SCEHSC research findings to local & national audiences by utilizing innovative communication methods, tailoring print
and web-based materials and resources for intended audiences, and amplifying our reach through social media, and 4)
Evaluate the success of CEC activities through logic models and formative and summative evaluations.